US Ten Day Seminar on the Epidemiology and Prevention of Cardiovascular Diseases and Stroke

ABSTRACT
This proposal requests sponsorship for the 49th U.S. Ten-Day Seminar. Given the burden of cardiovascular
diseases (CVD) and stroke, it is highly appropriate to conduct professional training on epidemiology and
prevention. The goals of this proposal align with the NHLBI’s Strategic Goals to “enable and develop a diverse
biomedical workforce equipped with the essential research resources to pursue emerging opportunities in
science.” Training of such a workforce is a key element of the country’s readiness to address the health
challenges posed by CVD and the readiness to advance multi-component strategies that promote
cardiovascular health (CVH). A prepared workforce will need research competencies in CVD epidemiology,
biostatistics, prevention, behavioral and social sciences, policy, public health practice. This Seminar can
uniquely contribute to training scientists who can integrate evidence across these fields and translate research
findings into effective and impactful policy and practice. We seek primary sponsorship from the National Heart,
Lung, and Blood Institute (NHLBI), and if we receive a meritorious score we will request co-funding from
NIDDK, NINDS, the NIH Office of Disease Prevention, and the NIH Office of Behavioral and Social Sciences
Research. Other funders/partners for the Seminar are the American Heart Association via two council budgets
(Epidemiology and Prevention & Lifestyle and Cardiometabolic Health).
To assure the successful conduct of the Seminar, we will continue to:
1. Attract a faculty with both the knowledge of relevant content and the personal teaching skills
required for the effective conduct of this program, with a continuing emphasis on the recruitment
of faculty from underrepresented racial/ethnic groups (currently 38% of the faculty) and female faculty
members (currently 54% of the faculty);
2. Adapt program content to maintain its relevance to the training needs of the nation for health
professionals with appropriate career interests, while maintaining a consistent central focus on
the foundational methods in cardiovascular disease epidemiology;
3. Disseminate information about this program to appropriate groups, using the most effective
current strategies for reaching underrepresented racial/ethnic groups, female candidates and
historically marginalized groups; and
4. Recruit participants from populations that have been historically marginalized by connecting
with diverse professional societies and organizations, and sustained relationships with seminar
alumni.

Public health relevance
PROJECT NARRATIVE This proposal requests sponsorship for a unique training program, the United States Ten-Day Seminar on the Epidemiology and Prevention of Cardiovascular Diseases (CVD) and Stroke, which was established in 1975, and offered annually. Given the immense burden of CVD and stroke to this nation in terms of disability, death, inequities, and costs, this focus area is highly appropriate as a setting for professional training in research and dissemination of evidence supporting improved prevention and patient outcomes. The proposed training is in line with the NHLBI’s strategic vision, is a key element of our country’s readiness to address the public health and medical challenges posed by CVD; and is critical to our readiness to advance multi-component strategies that promote cardiovascular health for all.